Markers of Disease Progression in MECP2 Duplication Syndrome

? DESCRIPTION (provided by applicant): Mutations in the X-linked gene that encodes MeCP2 (MECP2) are the cause of Rett Syndrome in girls. MECP2 duplication syndrome is an X-linked genomic disorder that accounts for 1-2% of all cases of X-linked intellectual disability (ID), primarily in boys. It is characterized by recurrent respiratory infections, infantile hypotonia, ID progressive neurological declines, and poor to absent speech. Data suggest that there are two distinct clinical paths in this syndrome. One path affects an estimated 50% of the population and is characterized by a dramatic loss of motor skills (regression) that eventually leads to death before the age of 25 resulting from complications of recurrent lower respiratory infections, suggesting possible immune deficits. In contrast, the other path is milder and includes individuals who maintain their milestones and have fewer infections. No study has examined the basis for these two alternative disease paths, or the contributing factors that lead toward a path of decline. The age of regression onset varies between 3-16 years. In addition to specific clinical markers, we have recently discovered that there are immune markers associated with regression that may account for the high frequency of respiratory infections, including impaired functioning of Th1 cells that make the cytokine interferon gamma (IFN-γ), and lower vaccine titers. We have also found that decreased activity of the hypothalamic-pituitary-adrenal (HPA) axis (a marker of stress) is associated with regression. This application therefore proposes a longitudinal study consisting of three annual evaluations of the clinical, immune, and stress markers of regression in males between the ages of 3-12 years with MECP2 duplication syndrome. The specific aims are: 1) To determine whether increased respiratory infections, lower cognition, seizures, and increased social withdrawal predict regression status in MECP2 duplication syndrome, 2) To determine whether suppression of IFN-γ from Th1 cells and lower influenza vaccine titers predicts regression status, and 3) To determine whether HPA axis hypoactivity predicts regression status. Completion of this study will immediately affect clinical practice through implementation of better guidelines for yearly vaccines, and guidelines for possible immune therapy. It will also lay the foundation for a future treatment study testing whether drugs known to improve functioning of TH1 cells normalize or improve clinical course, enhance HPA axis activity, and therefore improve quality of life. Finally, completion of our aims will also have broader public health significance for autoimmune disorders consistently associated with MeCP2 overexpression, including: lupus, Sjögren's syndrome, and rheumatoid arthritis.

Public health relevance
PUBLIC HEALTH RELEVANCE: MECP2 duplication syndrome is an X-linked disorder associated with distinct clinical outcomes including regression/loss of skills, but it is not yet known why some individuals convert to a path of decline while others maintain/gain milestones. In this study, we will identify the clinical signs, immune markers, and stress markers of regression so we can implement better guidelines for yearly vaccines, and so that we can lay the foundation for a future treatment study testing whether drugs known to improve immune functioning normalize or improve clinical course, normalize stress markers, and therefore improve quality of life. This study may have impact for other disorders with high rates of regression such as Rett syndrome and autism, where immune-mediated factors may contribute to clinical outcomes, and for autoimmune disorders associated with MeCP2 overexpression, including lupus, Sjögren's syndrome, and rheumatoid arthritis.